Biobehavioral mechanisms of smartphone-based cognitive emotion regulation training for unpaid primary caregivers of persons with Alzheimer's Disease

Project Summary / Abstract
Alzheimer’s Disease (AD) and Alzheimer's Disease-Related Dementias (ADRD) not only exact a heavy
toll on patients, they also impose an enormous emotional, physical, and financial burden on unpaid, often
family, caregivers. The strain of providing care for a loved one diagnosed with AD, often across several years,
is associated with elevated depression risk and poorer overall health. Existing cognitive and behavioral
intervention approaches for ADRD unpaid primary caregivers operate via biobehavioral mechanisms that
remain to be clarified. In addition, existing interventions target many components and strategies
simultaneously, making inferences about the effectiveness of particular strategies difficult to draw, and involve
substantial time/cost burdens. Emotion regulation skills represent an ideal target for psychological intervention
to promote healthy coping in ADRD caregivers. The proposed research seeks to use an experimental medicine
approach to test the efficacy and biobehavioral mechanisms of a novel, relatively brief, targeted, scalable,
entirely smartphone-based cognitive emotion regulation intervention aimed at improving psychological
outcomes (i.e., reducing perceived stress, caregiver burden, and depressive symptoms) in ADRD unpaid
primary caregivers as well as examine potential benefits of the caregiver intervention on quality of life in care
recipients. Cognitive reappraisal (i.e., the ability to modify the trajectory of an emotional response by thinking
about and appraising emotional information in an alternative, more adaptive way) represents a highly
promising target for psychological intervention in ADRD caregivers. Reappraisal can be operationalized via two
primary tactics: psychological distancing (i.e. appraising an emotional stimulus as an objective, impartial
observer) and reinterpretation (i.e., imagining a better outcome than what initially seemed apparent). The
proposed project builds upon promising preliminary work to investigate the efficacy and underlying
biobehavioral mechanisms of a novel, one-week cognitive reappraisal intervention in this population, with
follow-up assessments at 2 weeks, 4 weeks, and 3 months. ADRD unpaid primary caregivers will be randomly
assigned to receive training in either distancing, reinterpretation, or a no regulation natural history control
condition, with ecological momentary assessments of self-reported positive and negative affect, remotely-
collected psychophysiological health-related biomarkers (i.e., heart rate variability data measured using
smartphone-based photoplethysmography), and health-related questionnaire reports. The proposed study
aims to mechanistically relate changes in psychological and psychophysiological function to prediction of
health-relevant behavioral outcomes during a novel emotion regulation intervention never before implemented
in this stressed, high risk group.

Public health relevance
Project Narrative Caring for a loved one diagnosed with Alzheimer’s Disease is highly stressful. The proposed project will investigate the biobehavioral mechanisms underlying a novel cognitive emotion regulation intervention in unpaid primary caregivers of persons diagnosed with Alzheimer’s Disease or Alzheimer's Disease-Related Dementias (ADRD) by examining how thinking about an emotional stimulus in a more adaptive way can predict changes in health-related behavior via changes in negative affect and psychophysiological health-related biomarkers. This work may hold clinical significance in the development of new interventions to improve emotional health and well-being in caregivers of persons with ADRD.